High-throughput 3D mapping of large mammalian brains via integration of precision tissue sectioning and light sheet imaging

Whole-brain mapping at the cellular and subcellular levels is crucial to systematically
understand brain functions and disorders. Recent developments in tissue transformation
techniques, such as CLARITY, SHIELD, MAP, ExM, CUBIC, and DISCO-based methods, have
made significant progress towards whole-organ molecular labeling and microscopic imaging by
rendering intact tissue chemically permeable and optically transparent. Alternative approaches
to generate 3D whole brain datasets are based on integration of block-face imaging and
mechanical tissue sectioning, such as the STP, FAST, and WVT methods. Though these
approaches have successfully enabled volumetric imaging of the mouse brain and contributed
substantially to neuroscience research, they are not realistically applicable to larger scale
mammalian brains. Currently, the only way to image large intact mammalian brain samples is to
dissect the sample into small blocks, followed by the processing and imaging of each block
individually. Not only is this process laborious and low-throughput but it causes excessive tissue
damage, making it nearly impossible to piece together a complete picture of a large sample
without information loss. Furthermore, large-scale studies that require using considerable
amounts of rodent brains are extremely laborious and time consuming based on current
technologies. As a high-throughput solution is urgently needed, LifeCanvas Technologies
proposes to pioneer new developments for efficient, automated processing and high-resolution
microscopic imaging of large scale mammalian brains. Specifically, our new technological
developments will focus on 1) an advanced vibrating microtome for automatic precision slicing
of samples as large as an intact human brain hemisphere. The vibrating microtome will be
optimized for slicing highly complex samples with minimal tissue damage, uniform thickness and
extremely even surface profile; and 2) an integrated volumetric imaging system consisting of the
vibrating microtome and a custom-developed, high-resolution light sheet microscope. The
system will perform serial tissue sectioning and imaging at unprecedented speed for a wide
range of samples, including rodent brains, expanded rodent brains, intact non-human primate
brains, and whole human brain coronal slabs. In this phase, we will build prototypes of the
instruments and demonstrate the functionality on expanded, intact mouse brains and a large
array of mouse brains. In the next phase, we will build user-friendly, ready-to-commercialize
instruments tested on human and non-human primate brains. We anticipate the new
developments will expand LifeCanvas’ current tissue clearing, labeling, imaging and quantitative
analysis pipeline, and offer the neuroscience community a complete solution for mammalian
brain high-throughput processing and volumetric imaging.

Public health relevance
The ability to efficiently generate comprehensive datasets from large mammalian brains would enable researchers to investigate these complex structures more efficiently and systematically. Towards this goal, LifeCanvas Technologies will develop new tissue processing and imaging instruments for high-throughput, high-resolution, automated volumetric imaging of various large-scale mammalian brains. Together with LifeCanvas’ state-of-the-art tissue clearing, labeling and analysis pipeline, the new developments will provide the neuroscience research community with powerful tools to generate unprecedented, comprehensive datasets for a large variety of mammalian samples, including rodent, non-human primate and human brains.